Research and Engagement on Adaptation for Climate and Health

Project Summary/Abstract
Once considered a distant threat, climate change is now dramatically increasing the likelihood of
potentially preventable adverse impacts on human health and wellbeing.1 Implementing evidence-based
policies, programs, and interventions, collectively called adaptation, is an urgent challenge.2 Prioritizing
evidence-based adaptation interventions should be based on community perspective and priorities, practitioner
expertise, and scientific information on risks and risk reduction effectiveness.3 Implementation science can
support adaptation at scale by identifying factors affecting uptake of evidence-based interventions.4,5 The
mission of the University of Washington (UW) Research and Engagement on Adaptation for Climate and
Health (REACH) Center is to leverage implementation science in support of implementing evidence-based
health adaptation at scale.
The University of Washington is an outstanding setting for developing an adaptation-focused climate
and health research center. The UW is a leading research institution with large training programs in the health
sciences and an outstanding record of community engaged research. The institution has strength in multiple
relevant disciplines and in implementation science in several domains, but does not yet have implementation
science programming focused on community-engaged climate change adaptation in the health sector. The
REACH Center’s focus on implementation science to advance adaptation is a key innovation in the field, and
the Center will also advance several other innovations, including a novel climate and health decision support
tool (the Climate and Health Risk Tool, or CHaRT), a new climate and health implementation science
curriculum, a new interdisciplinary planetary health curriculum at the UW School of Medicine, a suite of pilot
climate and health intervention activities in communities in the Pacific Northwest, and community engagement
activities in support of the research project and the climate and health interventions.

Public health relevance
Project Narrative The mission of the University of Washington (UW) Research and Engagement on Adaptation for Climate and Health (REACH) Center is to leverage implementation science in support of implementing evidence-based health adaptation at scale. The REACH Center will also advance several other innovations, including a novel climate and health decision support tool (the Climate and Health Risk Tool, or CHaRT), a new climate and health implementation science curriculum, a new interdisciplinary planetary health curriculum at the UW School of Medicine, a suite of pilot climate and health intervention activities in communities in the Pacific Northwest, and community engagement activities in support of the research project and the climate and health interventions.